Genetic analysis of signaling pathways in cilia assembly and remodeling

PROJECT SUMMARY
Primary cilia mediate transduction of all major signaling pathways, which in turn modulate cilia
morphology and functional outputs. The research in my lab is focused on identifying new genes and mapping
signaling networks that regulate cilia assembly during development and cilia remodeling in response to
environmental stress at single-cell resolution in vivo. To pursue these research questions, we use sophisticated
molecular genetics, proteomics, and live imaging approaches in C. elegans with complementary studies in
mammalian cell culture models. In the next five years, we propose to address three research goals. A first
major goal is to define molecular mechanisms that regulate heterotrimeric G protein signaling during cilia
morphogenesis. Heterotrimeric G proteins and their canonical activators G protein coupled receptors (GPCRs)
localize to cilia, modulate cilia morphology, and when disrupted cause genetic disorders in humans. Key
outstanding questions that we propose to address are: What conserved and species-specific mechanisms
regulate ciliary trafficking of heterotrimeric G proteins? How do non-canonical, GPCR-independent
mechanisms modulate functions of ciliary G proteins? A second major goal is to determine in vivo mechanisms
that regulate and mediate cilia remodeling in response to stress. After exposure to environmental stress,
primary cilia undergo structural remodeling, which is associated with altered signaling output. We want to know
how stress modulates signaling capacity of cilia in vivo. What are the stress- and cell-specific mechanisms of
stress-induced cilia dynamics? A third major goal is to identify new conserved genes and pathways in cilia
morphogenesis and function. Cell- and tissue-specific differences in the ciliogenic programs are not well
understood, and the causative genes for many ciliopathy cases are unknown. For example, nearly 40 percent
of individuals with neurodevelopmental ciliopathies are estimated to be without genetic diagnosis. We want to
harness the power of bioinformatic approaches and C. elegans genetics to ask – what are the developmental
mechanisms that operate in cell-specific contexts to assemble cilia? Collectively, these projects will generate
fundamental insight into cell-specific signaling networks that regulate cilia assembly, remodeling, and cilia-
mediated cellular functions. This knowledge is an important steppingstone toward better understanding of the
genetic basis of ciliopathies, and more broadly, of mechanisms that allow cells to communicate with their
environment. This award would also allow us to recruit and train a diverse pool of researchers, launch new
collaborations, and follow new hypotheses that emerge in the course of this study.

Public health relevance
PROJECT NARRATIVE Primary cilia concentrate molecular machinery of all major signaling pathways thus allowing cells to communicate with their environment, and cilia defects cause a spectrum of disorders called ciliopathies. The proposed research is relevant to public health because it aims to identify new genes and map pathways in cilia assembly and post-developmental remodeling. This fundamental knowledge has the potential to facilitate development of therapeutic strategies to manage human conditions caused by anatomical and functional cilia abnormalities.